A New Paradigm for Iron Replacement Therapy

Project Summary/ Abstract
Anemia impacts ~25% of the world’s population and contributes to adverse outcomes. Several forms of anemia,
including anemia of inflammation (AI) and iron-refractory iron deficiency anemia (IRIDA) are caused in part by
pathologic iron (Fe) restriction. In these conditions, chronic immune activation or genetic mutations upregulate
the Fe regulating hormone hepcidin, which in turn inhibits activity of ferroportin, the only known Fe exporter.
Hepcidin excess thus imposes a severe form of hypoferremia as Fe liberated via hemoglobin recycling in
macrophages, nutritional iron absorbed by enterocytes, and other stored Fe cannot be exported to the plasma
iron-carrier protein transferrin for distribution.
Fe replacement in patients with hepcidin excess can be challenging. Most intravenous Fe replacement drugs
are Fe-carbohydrate nanoparticles that are accumulated and metabolized in macrophages, requiring ferroportin
for Fe mobilization. Thus, iv replacement can simultaneously have limited efficacy for anemia correction while
potentially contributing to Fe overload in macrophages. Hepcidin-driven Fe restriction also limits the efficacy of
nutritional Fe supplements. There is no clinically available hepcidin-modulating drug. Erythropoiesis stimulating
agents (ESA) may offer a therapeutic benefit for some patients, but are associated with cardiovascular toxicity,
thrombosis, and malignancy in some studies.
An alternate approach is to deliver Fe directly to transferrin via mechanisms independent of ferroportin. An
intravenous formulation comprising iron pyrophosphate citrate (FPC) that releases Fe directly to transferrin has
FDA approval for use during hemodialysis. However, care must be taken to ensure that serum FPC
concentrations do not exceed serum total Fe binding capacity, as exposure to toxic labile Fe occurs above this
threshold. To safely administer therapeutically meaningful quantities of Fe, FPC is slowly infused over hours.
There remains an unmet need for drugs to efficiently and safely replenish Fe via ferroportin-independent
pathways. We posit that a highly effective direct-to-transferrin Fe replacement drug can be developed through
the judicious application of coordination chemistry principals. Here, we propose drug design based on a set
prospectively defined molecular properties. Preliminary in vitro and in vivo data in support of our approach is
provided using the complex Fe-BBG (BBG = N,N-(bis)-2-hydroxybenzyl-L-glutamic acid) that we synthesized as
our initial drug prototype. We will iteratively synthesize and screen a library of complexes for efficacy and safety
signals. Promising candidates will be advanced to demonstrate therapeutic efficacy for anemai correction in
rodent models of IRIDA and chronic kidney disease. The output of this work will be one or more de-risked
candidates for development as direct-to-transferrin Fe replacement drugs.

Public health relevance
Project Narrative Several anemias, are caused in part by pathologic iron sequestration. In these conditions, chronic immune activation or genetic mutations upregulate the Fe regulating hormone hepcidin, which inhibits the mechanism by which bioavailable iron is mobilized to the extracellular iron-carrier protein transferrin for distribution. Anemia correction in the presence of hepcidin excess can be challenging, as hepcidin-driven iron sequestration also limits the efficacy of iron administered through replacement therapy or nutritional supplementation. This proposal is to develop a new class of direct-to-transferrin iron replacement therapy to efficiently and safely replace iron in anemias with hepcidin excess.